Molecular and genetic regulation of myelin capacity in the CNS

PROJECT SUMMARY
The myelin sheath is a multilayered membrane generated by specialized glial cells called oligodendrocytes
(OLs) that iteratively spiral their plasma membranes around axon segments in the central nervous system
(CNS) of vertebrates. Myelination serves to increase the conduction velocity of action potentials, and OLs
provide trophic support that is vital for neuronal survival. The importance of myelin in human health is
underscored in diseases in which it is disrupted, like leukodystrophies and multiple sclerosis. Despite the
importance of myelin, we lack a complete understanding of the molecular and genetic mechanisms that govern
OL development and myelination; additionally therapeutic strategies to promote remyelination are sorely
lacking. This proposal focuses on two critical regulators of OL development and myelination: Fbxw7 and Myrf.
Loss of Fbxw7, a ubiquitin ligase component, in animal models leads to increased amounts of myelin
formation, whereas loss of Myrf results in a lack of myelination. Fbxw7 targets Myrf for degradation, and we
hypothesize that Fbxw7 functions to limit myelination in the CNS by acting, at least in part, by controlling Myrf
levels. In this proposal, we will employ a synergistic combination of zebrafish and mouse models to: 1) define
the cellular mechanisms by which Fbxw7 regulates OL development, myelination, and myelin homeostasis; 2)
determine the role of Fbxw7 in remyelination; 3) Define the cadre of myelin-promoting Fbxw7 targets in OLs,
with a particular focus on Fbxw7’s regulation of Myrf. These experiments will enhance our understanding of OL
biology and may lay the foundation for future therapeutics that stimulate myelin repair in humans.

Public health relevance
PROJECT NARRATIVE Lack of robust remyelination represents a major barrier in the recovery from neurological function in diseases like multiple sclerosis. Here, we propose to determine how the extent of CNS myelination is controlled in development, homeostasis, and repair focusing on two key genes with opposing roles. These studies can lay the foundation to help define new strategies to stimulate remyelination in the injured and diseased human nervous system.